Targeting tumor cell macrophage lipid interactions to overcome resistance to androgen receptor targeted therapy

Abstract
Tumor-associated macrophages are key effector immune cells that promote prostate cancer progression.
Studies in other cancers show that macrophage secrete cytokines, angiogenic mediators and/or metabolites to
drive resistance to various therapeutics. Here we sought to determine the role of macrophage altered metabolism
in driving resistance to androgen receptor (AR) targeted therapy. Unbiased transcriptomic analysis of prostate
tumors following macrophage depletion revealed that macrophage infiltration was associated with molecular
signatures of AR activation and cholesterol transport. These findings were recapitulated in vitro, with the co-
culture of macrophages and prostate cancer cells enhancing AR nuclear localization, increasing cancer cell
proliferation in androgen-deprived conditions, and reducing sensitivity to the AR antagonist, enzalutamide. We
then characterized role of cholesterol in macrophage tumor cell lipid interaction and AR activation and identified
the transcriptional regulator of cholesterol metabolism LXR as a novel mediator of macrophage-induced AR
activation. Accordingly, we hypothesize that altered macrophage metabolism in prostate cancer drives resistance
to AR-targeted therapy via LXR dependent perturbation of cholesterol transport and biosynthesis. The
cholesterol exchange may be further propelled by metal ion availability in tumor microenvironment as our new
findings suggested. To address this, we propose to 1) Determine the mechanisms by which macrophages drive
resistance to androgen receptor targeted therapy. 2) To evaluate the therapeutic potential of targeting
macrophage-tumor cell lipid interactions to overcome resistance to AR inhibitors. The goal of this project is to
identify metabolic liabilities in tumor microenvironment that can be targeted to achieve cure in prostate cancer
patients.

Public health relevance
PROJECT NARRATIVE. Macrophages represent the dominant population of immune cells within prostate tumors. Here we will determine how exchange of cholesterol and metal ions drive resistance to androgen receptor targeted therapy.